The Neurobiology of Language Conference

DESCRIPTION (provided by applicant): A total of 221 abstracts were submitted to NLC 2009, representing twenty different countries and four continents. Country Number of Abstracts Australia 3 Belgium 2 Brazil 3 Canada 13 Chile 3 Finland 3 France 10 Germany 19 Israel 3 Italy 6 Japan 2 Lebanon 1 Netherlands 3 Russian Federation 1 Spain 4 Sweden 1 Switzerland 5 Taiwan 1 United Kingdom 22 United States 116 Total 221 PUBLIC HEALTH RELEVANCE: Our goal is to organize international annual meetings on the Neurobiology of Language. The neurobiology of language is becoming a major concern for neuroscientists, as new methodological developments now allow a robust neuroscience of language. Language neuroscientists come from a broad spectrum of disciplines, and rarely, if ever, attend the same meetings. The neurobiology of language conference is an interdisciplinary conference that provides a unique opportunity to bring together junior and senior researchers to foster interaction, collaboration, and new approaches to understanding the neurobiology of language.

Public health relevance
Our goal is to organize international annual meetings on the Neurobiology of Language. The neurobiology of language is becoming a major concern for neuroscientists, as new methodological developments now allow a robust neuroscience of language. Language neuroscientists come from a broad spectrum of disciplines, and rarely, if ever, attend the same meetings. The neurobiology of language conference is an interdisciplinary conference that provides a unique opportunity to bring together junior and senior researchers to foster interaction, collaboration, and new approaches to understanding the neurobiology of language.